Thymic output, lymphocyte activation and turnover

Pathogenic events resulting from high viral replication during acute HIV infection, and the immune responses to the virus determine the ultimate level of HIV in a patient, and also the emergence of occasional individuals who are able to control HIV without drug therapy. Three interrelated perturbations in normal immunological responses include: impaired development of HIV-specific CD4 cells, defective antigen presentation, and hyperactivation of T cells with disruptions in T cell production and turnover. Project 4 examines the effects of high viremia in acute HIV infection on thymic output, whether a decrease in recent thymic emigrants (RTEs) is polyclonal or oligoclonal, and the relative contributions to the distortion and loss of diversity of the TCR repertoire, and the loss of HIV-specific CD4 cells (projects 1 and 3) of a) large numbers of CD4 cells entering cell cycle, b) decreased RTEs and c) the effects of decreased TCR alpha chains on beta-alpha chain pairing. The effects of antiretroviral therapy in partially reversing these abnormalities also will be studied. RTEs will be identified by a unique surface phenotype as assessed by multicolor flowcytometry and by the alpha/beta TREC ratio that is influenced by intrathymic proliferation but not by peripheral dilution. The hypothesis will be examined that an HIV-initiated large increase in the production of interferon-alpha by the plasmacytoid DC (in collaboration with project 2) is responsible for the decrease in intrathymic proliferation.